San Diego Nathan Shock Center

ABSTRACT
While aging is characterized by progressive, systemic, physiological, and cellular declines, the degree to which
these occur is highly heterogeneous, particularly among older adults. The goal of this supplement to the San
Diego Nathan Shock Center (SD-NSC) is to create new opportunities for the aging research community study
the heterogeneity of human aging. The SD-NSC generates novel tools, resources, and training opportunities to
enable studies into the heterogeneity of human aging. Central to these activities is the Human Cell Models of
Aging Core that is currently enrolling a new human clinical cohort (the SD-NSC-CC) representative of the adult
lifecourse (20-85+ years old). We propose to enhance the SD-NSC-CC by enrolling older adult participants from
the Rancho Bernardo Study (RBS), one of NIH’s longest population-based observational cohorts that includes
longitudinal clinical assessments. To date, RBS participants have undergone up to seven physical and cognitive
assessments over 28 years, allowing us to enroll RBS participants representing different trajectories of healthy
aging. The specific aims of this supplement are: 1) to provide biological samples and data resources to enable
researchers to determine how age-dependent health trajectories relate to the heterogeneity aging, 2) to facilitate
the development of novel human cell models of aging that are linked to longitudinal data from the RBS, and 3)
to utilize existing SD-NSC infrastructure to advertise the availability of these new resources to the aging research
communities. We will co-enroll into the SD-NSC-CC, 40 RBS participants (≥ 65 years old) representing a range
of long-term aging trajectories (i.e. biological ages), including resilience and susceptibility to long term physical
and cognitive decline. Fibroblasts, plasma/serum, and blood cells will be collected and banked and made
available to the biology of aging research community. The Human Cell Models of Aging Core also generates
iPSCs and other induced cell types (e.g., neurons) from fibroblasts that maintain cellular aging features of the
donor. By including RBS patients with known cognitive and physical function trajectories in this pipeline, we will
significantly augment the library of cell models being generated by the SD-NSC, thus increasing the impact of
both the RBS and SD-NSC for the research community. The current SD-NSC-CC cognitive battery will also be
expanded to match RBS cognitive assessments, to enable the collection of new longitudinal cognitive data.
Finally, the SD-NSC provides pilot funding to support heterogeneity of aging research projects, the scope of
which will be expanded to include those using these new resources. In summary, this supplement will multiply
the value of both the SD-NSC and the RBS and enhance the resources needed by the biology of aging research
community to understand the heterogeneity of human aging.

Public health relevance
PROJECT NARRATIVE The San Diego Nathan Shock Center (SD-NSC) provides novel tools, resources, and training workshops to enable studies into the heterogeneity of human aging. This supplement proposal seeks to expand upon the unique SD-NSC clinical cohort by enrolling participants from the Rancho Bernardo Study (RBS) that exhibit a range of long-term physiological trajectories, including resilience as well as susceptibility to age-related decline. By leveraging the ~50 years of longitudinal data and biological samples associated with RBS and establishing a new biobank of human cell lines from these individuals, we will create unique opportunities for the biology of aging research community to understand the heterogeneity of human aging.